Data Science Core

PROJECT SUMMARY (DATA SCIENCE CORE)
The Data Science Core (DSC) aims to support research efforts to control the TB pandemic through
expansion and enhancement of TB-focused data science. Data science plays an important role in a broad
spectrum of activities throughout the iterative cycles of productive research, including study design, assay
development, data processing, statistical analysis, data visualization, mathematical modeling, and
communication of findings. The DSC aims to enhance data science for TB by building initiatives to improve data
science literacy and catalyze cross-disciplinary collaborations between TRAC researchers and New-to-TB data
scientists (Aim 1), as well as to directly enable increased utilization of data science approaches in TB research
(Aim 2). Aim 1 objectives will be achieved through virtual trainings paired with office hour consultations, as well
as the organization of annual semi-structured, TB-focused Hackweeks and meet-up events. The DSC will
accomplish Aim 2 objectives by providing hands-on data science assistance to TRAC researchers in the form of
targeted consultations, limited-scope catalytic analyses, and broader collaborative efforts. We will support these
activities by directly supporting partial salary of data scientists at FHCRC and SCRI in addition to the co-directors.
New-to-TB data science collaboration will also be encouraged by a diverse group of DSC Faculty Partners—
data science experts who have extensive experience studying TB. Faculty Partners have agreed to provide their
analytical expertise for collaborations and consultations in subjects that include stochastic modeling, software
development, biostatistics, image analysis, lab data management, structural biology, systems biology, and
epidemiology. An additional Industry Partner will help subsidize cloud-computing costs for this work and help
train TRAC researchers on how and when to utilize cloud-computing resources. Together, the combination of
training, community building, and hands-on data science activities that the DSC will establish will work in tandem
with the other TRAC Cores to directly amplify TB science, catalyze new collaboration on TB-related questions,
and expand the number of TB scientists in our community.